Center for Implementation Science

SUMMARY
The overarching goal of this COBRE is to establish a multidisciplinary research program in implementation
science at Dartmouth College and to provide training, expert mentorship and new scientific infrastructure to
train and support a critical mass of early-stage investigators as they transition into independent investigators
dedicated to advancing the field of implementation science. Implementation science is the study of methods to
promote the integration of research findings and evidence into healthcare policy and practice as a critical
emerging discipline in biomedical research. This multidisciplinary field combines methods from medical
anthropology, healthcare and behavioral economics, intervention effectiveness and process research,
improvement science, education and learning, social psychology, organization and management, and
marketing. Currently, there is $3 billion annually in federal funding for implementation research. Yet, there is a
critical gap in academic development opportunities for junior faculty to be trained and mentored in the
implementation sciences or resources to increase their academic trajectory towards independence. Despite the
escalation in funding and the unique needs of IDeA states for effective biomedical health interventions, IDeA
states continue to lag in implementation research funding. Therefore, we propose to build state-of-the-art
infrastructure in implementation science to accelerate biomedical research funding for implementation in the
IDeA state of New Hampshire, and create systems and training opportunities for use by other IDeA states
regionally and nationwide. Our proposed Center for Implementation Science, supported by Centers of
Biomedical Research Excellence (COBRE) mechanism, will support and advance research by junior faculty,
building on Dartmouth’s recognized academic and research excellence. The proposed Center will support five
research project leaders and will address the following specific aims: Aim 1: To establish a multidisciplinary
COBRE Center for Implementation Science; Aim 2: To implement and sustain a vibrant organization and
management plan for the Center; and Aim 3: To accelerate the transition of junior faculty into NIH grant-
competitive, strong? independent investigators. Impact: The proposed Center for Implementation Science will
provide needed funding, new scientific resources, and mentorship to advance junior faculty into independent
research careers focused on the study and application of implementation science. The initial research projects
will support the development of a self-sustaining, multidisciplinary, research program in implementation
science and provide a needed resource for IDeA Centers for Biomedical Research Excellence nationally to
foster national collaboration and accelerate NIH funding independence.

Public health relevance
NARRATIVE The overarching goal of the Center for Implementation Science supported by Centers of Biomedical Research Excellence (COBRE) is to establish a multidisciplinary research program in implementation science at Dartmouth College and to provide training, expert mentorship and new scientific infrastructure to train and support a critical mass of junior faculty as they transition into independent investigators dedicated to advancing the field of implementation science and biomedical research.